A mouse model with humanized telomere homeostasis

Abstract
The goal of this project is to develop a mouse model that acquires human-like telomere
homeostasis for the study of human aging, cancer, and other age-related diseases. In humans,
most somatic cells lack telomerase expression and cannot replenish their telomeres. Telomeres
progressively shorten upon successive cell divisions, functioning as an aging clock.
Consequently, telomere attrition is a critical factor of human aging and telomere stabilization,
predominantly via telomerase activation, is an essential event in the development of most
human cancers. On the other hand, many other organisms, including laboratory mice, do not
exhibit telomere-mediated replicative aging. Mice possess long telomeres and ubiquitous
telomerase activity in adult tissues. This interspecies difference has become a bottleneck for
addressing many fundamental questions in human aging and cancer biology using mouse
models. To tackle this challenge, we have started to create a mouse strain with humanized
telomere homeostasis. We have engineered a humanized mouse Tert allele (hmTert) by using
regulatory sequences from the human TERT gene (hTERT) to replace their mouse
counterparts. We found that the hmTert gene regulation recapitulated that of the hTERT gene
during mouse development and in mouse adult tissues. Remarkably, the hmTert allele imposed
a much shorter telomere length setpoint than the wildtype mTert gene in mice. In this application,
we propose three specific aims: 1) Create a mouse strain with hmTert alleles and human-like
short telomeres; 2) Study replicative aging in mice with humanized telomere homeostasis; and 3)
Determine lifespan and health-span of mice with humanized telomeres.

Public health relevance
Project Narrative While telomere shortening is a key mechanism of human aging, laboratory mice do not exhibit telomere-mediated aging. In this application, we plan to develop a genetically engineered mouse strain with humanized telomeres. Such mice should become an improved model for studying human aging and cancer.